BRCA-dependent Mechanisms of Genome Maintenance and Repair

ABSTRACT
DNA double-strand breaks (DSBs) are among the most deleterious of DNA lesions and, if not
handled properly, can lead to gross chromosome aberrations, neoplastic transformation of cells, and
tumorigenesis. The NCI-funded research program of the Unit Director Dr. Patrick Sung has focused
on elucidating conserved homologous recombination (HR) mechanisms, by which DSBs are being
faithfully repaired. Through a transdisciplinary approach encompassing biochemical reconstitution,
biophysical analysis, structural biology, and cell-based investigations, the Sung laboratory has
provided insights into critical steps of HR. The available experimental and intellectual framework
ideally positions us to continue delineating the mechanistic intricacy of HR and DSB repair processes,
to provide actionable information for explaining why HR gene mutations lead to genome instability,
replication fork demise, neoplastic cell transformation, and cancer.
As Research Associate Professor, I have been making contributions in elucidating the underlying
mechanisms of three critical stages of HR, namely, RAD51 presynaptic filament assembly, DNA
strand invasion, and repair DNA synthesis. I have also played a key role in the training and mentoring
of graduate students and research fellows in the Sung laboratory. In this R50 Research Specialist
Award application, I request salary support to enable me to help drive research endeavors directed
at elucidating the multifaceted roles that the tumor suppressors BRCA1-BARD1, BRCA2, FANCJ,
and their companion HR factors fulfill in the aforementioned stages of the HR process and in DNA
replication fork preservation. As such, the R50 Research Specialist Award will not only help advance
our research objectives, but will also exert a broader impact in the DNA repair and cancer biology
fields as I continue to devise novel biochemical assays and systems reconstituted with purified HR
factors to facilitate the studies of other laboratories, and will help identify novel targets and pathway
pivot points to spur the development of small molecule compounds as chemical biology tools and
potential cancer therapeutics. 【 I will continue to advise the Unit Director in all matters concerning
the general directions of our research program, take on major responsibilities in mentoring and
training of doctoral students and postdoctoral fellows, and act as the main conduit with intramural
and extramural collaborators. I will serve as the corresponding author on studies in which I have
played a leadership role, attend major conferences to disseminate my research findings, and
develop a national reputation based on my own merit. 】

Public health relevance
Project Narrative The main objective of this R50 proposal is to seek support for a Research Specialist Dr. Youngho Kwon to apply his class-leading expertise to enhance the productivity and impact of a long-standing NCI-funded research program at University of Texas Health San Antonio, and to enable Dr. Kwon to achieve higher autonomy and further career growth. Our NCI-funded program is aimed at deciphering the mechanistic underpinnings of DNA break repair and DNA replication fork preservation via the homologous recombination (HR) pathway that is mediated by several tumor suppressors, including BRCA1-BARD1 and BRCA2. The continual involvement and leadership of Dr. Kwon will exert a broader impact in DNA repair studies and the cancer biology field at the national level, and will also furnish the intellectual and experimental framework for the development of cancer therapeutics.